Predictors of hemorrhage among patients on direct acting oral anticoagulants

ABSTRACT:
Direct acting oral anticoagulants (DOAC), specifically rivaroxaban (RIVA) and apixaban (APX) have emerged
as the most commonly used oral anticoagulants, replacing warfarin in patients with atrial fibrillation (AF) and
venous thromboembolism (VTE). However, hemorrhage (HEM) is the most feared adverse effect and is a
critical barrier to institution of these efficacious therapies. Anticoagulants have consistently ranked as the top
offenders for adverse drug event related hospitalizations in the US, with HEM accounting for ~80% of
adm is s ions .
To predict HEM risk, investigators have developed clinical prediction rules (CPRs) focused mainly on warfarin-
related HEM. However, the lack of CPRs for DOAC-related HEM, the variable inclusion of antiplatelets, the
lack of assessment of gastro-protective therapies or interacting drugs (influencing APX and RIVA
pharmacokinetics), the lack of assessment of risk across the spectrum of kidney function, and the scarce (to
nil) representation of Blacks are critical knowledge gaps. Identifying factors contributing to the increased
HEM risk among APX and RIVA users and elucidating their impact (effect size) is of critical importance
In this application, we aim to identify predictors of HEM risk and define the impact (effect size) in a clinical
cohort of medically complex, racially diverse patients on APX (n=1500) and RIVA (N=1500) and develop CPRs
for APX-related-HEM and RIVA-related-HEM.
Through Aim 1, we will identify and assess the influence of predictors (e.g. demographics, comorbidities) on
risk of HEM. In Aim 2, we will elucidate the influence concomitant use of antiplatelet therapy, gastro-protective
therapies (proton pump inhibitors and H2 Receptor Blockers) and interacting drugs (amiodarone, diltiazem and
verapamil) on risk of HEM among RIVA and APX users. Aim 3 will focus on determining the influence of
chronic kidney disease (CKD) spectrum on HEM risk and elucidate steady state pharmacokinetics (PK) and
pharmacodynamics (PD) across the spectrum of kidney function among RIVA and APX users. Finally, Aim 4
will incorporate results from Aims 1-3 into building CPRs to personalize the prediction of HEM among APX and
RIVA users. The prediction models will validated in an independent cohort (n=500 APX, n=500 RIVA).
Our focus on complex patients seen in clinical practice with robust representation of understudied patients
(Blacks, patients with moderate and severe-CKD) and assessment of common co-medications improves
generalizability and applicability to real world patients.

Public health relevance
Public health Narrative: Identification of factors that predict risk of hemorrhage among patients taking direct acting oral anticoagulants is vital as it can help identify patients who stand to benefit or be harmed by anticoagulants drugs. The integration of these predictors into the current treatment approach can help provide personalized treatment, improving outcomes for the individual patient. The increasing burden of atrial fibrillation in the US and the world, highlight the immense potential of such research in facilitating the realization of tangible individual and population health benefits.